Modeling the Role of PrEP in Getting to Zero

PROJECT SUMMARY/ABSTRACT Progress in HIV prevention in the United States (US) has stalled, according to reports from the Centers for Disease Control and Prevention (CDC) (1). Most recently, the Department of Health and Human Services has made Ending the HIV Epidemic (EHE) a national priority (6), with intermediate goals of a 75% reduction within five years and a 90% reduction in 10 years (7). GTZ programs rely on the concept of combination HIV prevention, using evidence-based methods that have been tailored to suit local needs (8-11). Among each of these programs is an emphasis on pre-exposure prophylaxis (PrEP), which is a versatile tool able to prevent acquisition of HIV infection within diverse HIV-risk communities. Despite the success of PrEP in efficacy trial settings, uptake has been slow in the US and highly variable: coverage among those with indications for PrEP is estimated to range from 5-41% (median 18%), among US states (20). Agent-based stochastic modeling is highly equipped to investigate complex epidemiologic questions, such as the effects of the PrEP continuum in diverse settings, populations, and as part of combination HIV prevention. The HIV Calibrated Dynamic Model (HIV-CDM), simulates HIV testing, transmission, treatment, and prevention among a wide range of epidemic settings and is able to address the crucial questions facing PrEP implementation in the US (40-43). Using the HIV-CDM, we propose to address the following aims: Specific Aim 1: To expand and calibrate the current HIV-CDM to capture the epidemic dynamics, HIV risk behavior, network mixing, and access to HIV prevention modalities within the most prominent GTZ programs and priority settings throughout the US. Specific Aim 2: To simulate the PrEP continuum in each of the specific settings noted below, including PrEP eligibility within key populations, access, retention, and adherence. To inform these simulations, and generate estimates for PrEP utilization up to 10 years into the future, we will integrate empirical data for each step of the continuum. This will include a focus on both the development and testing of diverse PrEP eligibility measures, including electronic health record-based algorithms, clinical checklists, and CDC guidelines. Specific Aim 3: To evaluate the potential to reduce HIV incidence by 75% in five years, and 90% by 2030, through targeted PrEP expansion, within the context of existing combination prevention packages in settings with a history of HIV prevention successes (e.g., Boston and San Francisco), settings that have struggled in their GTZ efforts (Miami, Atlanta), and rural settings that are priority areas for the new EHE initiative. This approach will include network-based analyses that will investigate the most efficient methods of PrEP delivery within heterogenous epidemics.

Public health relevance
PROJECT NARRATIVE This proposal is to use an agent-based HIV transmission model, the HIV Calibrated Dynamic Model (HIV- CDM), to evaluate the role of the PrEP care continuum in the Getting to Zero/Ending the Epidemic (EHE) campaigns in the United States. We will expand the HIV-CDM to incorporate the behavioral and epidemic data for men who have sex with men (MSM), men who have sex with men and women (MSMW), people who inject drugs (PWID) and heterosexuals. Using the HIV-CDM, we will model the population level impact of maximizing the PrEP continuum (identification, testing, linkage, access, and retention) on the EHE goals of 50% and 90% reduction in HIV incidence over the next 5 and 10 years, respectively.